Macrophage Lipid Homeostasis and Inflammatory Signaling

Project 2: Macrophage Lipid Homeostasis and Inflammatory Signaling
ABSTRACT/SUMMARY
The objective of Project 2 of this PPG is to understand how cellular lipid composition and lipid trafficking
influence the inflammatory function of macrophages. Although perturbations in lipid homeostasis are
recognized to be associated with inflammation in a number of human diseases, our understanding of “how”
and “why” remains limited. Recent work has revealed that pro-­inflammatory signals reprogram the lipid
metabolic state of macrophages. It has also become clear that perturbations in lipid homeostasis can be
sensed by the inflammatory machinery of macrophages so as to induce and to regulate inflammatory
responses. Thus, lipid homeostasis and inflammation are interrelated, and perturbations in one affect the other.
In this project, our PPG team will combine advanced analytical mass spectrometry–based approaches with
genetic models of inflammation, with the goal of defining mechanisms by which inflammation drives
reprogramming of the lipidome (and vice versa). We will assess the consequences of changing the subcellular
levels of lipids on inflammatory signaling. Specific Aim 1 is to apply advanced analytic techniques to determine
how pro-­ and anti-­inflammatory signals change the subcellular lipidome in macrophages. We will use mass
spectrometry approaches, including shotgun lipidomics, NanoSIMS imaging, and isotope labeling, to
understanding how pro-­ and anti-­inflammatory signals influence lipid localization and trafficking in
macrophages. Specific Aim 2 is to determine the mechanisms by which alterations in cholesterol homeostasis
potentiate the STING signaling pathway. We will pursue our discovery that perturbations in de novo cholesterol
synthesis change type I IFN inflammatory responses via STING. Using a combination of biochemical
approaches, confocal and NanoSIMS imaging, and chemoproteomics, we will test the hypothesis that
cholesterol regulates STING function through direct binding. We will also test whether disease-­associated
mutations in STING abrogate the regulatory impact of cholesterol. Specific Aim 3 is to determine the
importance of the STING signaling pathway on the development of dyslipidemia, inflammation, and
atherogenesis in mice. Type I IFNs have been shown to influence the pathogenesis of atherosclerosis, but the
molecular pathways underlying this sterile inflammatory response have not been elucidated. We will test the
hypothesis that the cGAS/STING inflammatory axis is required to generate type I IFN in the setting of
dyslipidemia and atherosclerosis. These studies will define the influence of the STING pathway on
dyslipidemia, inflammation, immune cell infiltration, and atheroma development. It is our expectation that our
proposed studies will define, at a molecular level, why dysregulation of macrophage lipid homeostasis drives
inflammation, and how inflammation influences macrophage cholesterol metabolism in cardiovascular disease.
Our PPG team is excited by our hypotheses, and we are positioned, with all of the experimental approaches,
reagents, and expert collaborators, to make rapid progress.